2/2 Circulatory Support in Pediatric Heart Failure Patients Using the Jarvik 2015 LVAD: A Pivotal Trial

PROJECT SUMMARY/ABSTRACT
This collaborative grant application proposes (a) to conduct a multicenter single-arm pivotal clinical trial of the Jarvik 2015
left ventricular assist device (LVAD) as a bridge-to-transplant in 22 hospitalized children with severe heart failure (HF)
refractory to medical therapy; and (b) to generate the safety and effectiveness data necessary to support regulatory
review and potential FDA approval of the Jarvik 2015 LVAD under the Humanitarian Device Exemption (HDE) pathway.
The HDE pathway is FDA’s approval process for high-risk medical devices intended to treat rare and/or orphan diseases.
The need for safe, reliable, and dischargeable LVADs for smaller children with HF is well-established. Currently, the Berlin
Heart EXCOR Pediatric VAD is the only FDA-approved durable VAD for smaller children. While outcomes have improved,
the Berlin Heart has important limitations: (1) patients cannot be discharged on VAD support; (2) the paracorporeal design,
with large-bore cannulae traversing the abdominal wall results in a high incidence of wound complications; and (3) the
high pump thrombogenicity (especially around the valves) requires intravenous anticoagulants and intermittent pump
exchanges to preempt the risk of stroke. There is an enormous technology gap between contemporary adult VADs
(continuous flow [CF], magnetically-levitated, and safely dischargeable) and contemporary pediatric VADs (pulsatile,
pneumatically driven, non-dischargeable). In recent years, the Jarvik 2015 LVAD, a fully implantable CF device has emerged
as an alternative to the Berlin Heart. Data from the FDA’s Early Feasibility Study (EFS) suggest the Jarvik 2015 LVAD can
support smaller children successfully for up to a year or longer as a bridge to transplant. However, systematic data in a
22-subject Investigational Device Exemption (IDE) pivotal trial is required for FDA review and approval. The safety endpoint
is freedom from device-related stroke. The effectiveness endpoint is survival to transplant or 180 days in the absence of
severe stroke. The IDE received conditional FDA approval on June 4, 2021 (IDE# G160185).
The trial will be conducted at 14 centers in the US and Europe with a Clinical Coordinating Center at Stanford University
and a Data Coordinating Center at HealthCore, Inc. The investigator group has a strong history of collaborative research
and multicenter clinical trials, facilitating smooth execution of the proposed study. In accordance with FDA’s requirements
for approval of humanitarian devices, a pre-specified performance goal will demonstrate safety and effectiveness (≥17 of
22 subjects free of stroke, and ≥17subjects surviving to transplant or 180 days free of severe stroke: with central review
of clinical events and neuroimaging studies).
While safe, reliable, and dischargeable LVADs are widely available for adults, pediatric VAD technology lags behind by
multiple generations of technology. Moreover, children who safely survive their VAD course have a substantially longer
potential life expectancy making evaluation of newer pediatric VADs an urgent priority for the heart failure community.
This trial has the potential to take a crucial step in achieving that goal.

Public health relevance
PROJECT NARRATIVE This research study proposes to conduct a single-arm clinical trial in 22 children who are suffering from severe heart failure and require a mechanical heart pump as a bridge to a heart transplant. Unlike adult heart failure patients who have access to wide variety of safe and reliable heart pumps that permit hospital discharge, smaller children do not, leaving children and their families hospitalized for up to a year until a heart transplant becomes available. The purpose of this study to evaluate a promising new heart pump for smaller children, the Jarvik 2015, that closes this enormous technology gap between adult and pediatric devices, and to provide the type of safety and effectiveness data that the FDA requires to review and potentially approve a high-risk medical device for a rare/orphan disease, like children hospitalized for severe heart failure.